Aging Pilot Core

The Institute of Medicine and National Research Council workshop report on "The Future of Home Health Care”,
calls for care that is patient and person-centered, seamlessly connected and coordinated, high quality and
technology enabled. The overarching goal of the Aging Focus Pilot Core (Core G) is to promote the advancement
of science using technology and artificial intelligence to optimize health and care management for older adults
living in their homes independently, and those receiving skilled home and community-based services (H&CBS).
We capitalize on the opportunity to reach a national population receiving H&CBS which includes skilled home
health care (HHC), the Program for All-Inclusive Care for the Elderly (PACE), and Managed Long-Term Services
and Supports (MLTSS), in addition to healthy older adults living in the community. These populations of older
adults present an ideal opportunity to apply AI and technology to promote healthy aging and equitable access to
care and supports; address the needs of vulnerable older adults; avoid institutionalization; maintain quality of
life; and receive appropriate end-of-life care. We propose three aims: AIM 1. Establish a national network of
home care agencies, PACE sites, and MLTSS plans interested in supplying data and/or serving as test
sites for AI and technology solutions to support patients/members, providers, and family caregivers. The
Aim 1 outcome is a comprehensive national database of home care agencies, PACE sites, and MLTSS plans
interested in supplying data, serving as pilot test sites, or as purchasers of commercial products. The national
network of potential pilot sites and customers for commercial products developed through the Collaboratory will
grow each year through networks with our initial partners, contacts at national conferences, and outreach through
professional organizations. AIM 2. Foster collaborations among affiliated Penn investigators and our
network of peer institutions and research centers to grow a cadre of scientists to advance the science
of care within home and community-based services. The outcome of Aim 2 will be annual workshops that
build teams and educate investigators about the data sources, services, policies, and research questions
essential to promote the science of aging in place and bring products to market. AIM 3. Solicit, select,
develop/refine, and manage pilot studies that develop or test AI and technology applications to detect
risk, predict needs, address disparities, improve access to care, and support decision making for
chronic illness management and safe aging in place for older adults and their family caregivers.
Successful funding and completion of 2-3 funded pilot studies per year, dissemination of their results, and
commercialization of products brought to market that detect risk, predict needs, address disparities, improve
access to care, and support decision making for underserved and hard to reach older adults and their caregivers.

Public health relevance
The Aging Focus Pilot Core will promote the advancement of science using technology and artificial intelligence to optimize health and care management for older adults living in their homes independently, and those receiving skilled home and community-based services